Role of State Medicaid Policies in Improving Access to Dental Care among Low-Income Adults

PROJECT SUMMARY
The purpose of this study is to examine how access to dental care among low-income adults is impacted by
state Medicaid policies regarding eligibility, dental coverage, cost-sharing and dentist reimbursement. Oral
health is integral to overall health, economic productivity and well-being. Yet access to dental care continues to
be a major public health problem for low-income adults, leading to untreated disease, pain, poor systemic
health and substantial economic burden. In recent years, several policy changes under the Affordable Care Act
(ACA) such as Medicaid expansion and dependent care coverage could significantly impact access to dental
care among the poor non-elderly adults. In addition, there is extensive cross-state variation in terms of dental
benefits covered for Medicaid adults. These variations provide natural experiments to examine the effect of
Medicaid policies on access to dental care. Moreover, under the current health reform discussions, state
Medicaid programs are anticipated to gain autonomy in resource allocation, yet may receive significantly less
federal funding, making the need for robust evidence on relative effectiveness of Medicaid policy alternatives
available to the states paramount. The overarching goal of this application is to advance the research career of
the candidate (Dr. Singhal) by protecting her time for training and research on these critical issues in oral
health policy. This goal will be accomplished through additional training in complementary disciplines of
econometrics and machine learning, and their application to estimate the impacts of Medicaid coverage and
payment generosities on access to dental care. The project brings together complementary secondary data
from multiple sources including: large national survey data (National Health Interview Survey), administrative
enrollment and claims data (Medicaid Analytic eXtract) and linked survey and claims data. Leveraging these
data and training resources, this project will: 1) develop synthetic indices of Medicaid dental coverage and
payment generosities; 2) estimate the effect of each policy alternative and combined generosity indices on
various measures of access to dental care; and 3) predict the relative effectiveness of policy alternatives and
their combinations on access to dental care. We will use econometric methods including instrumental
variables, difference-in-difference and regression discontinuity models to develop the generosity indices and to
estimate the impact of Medicaid generosity. To develop and validate the predictive model, we will use
supervised machine learning approaches (e.g. decision tree learning) using linked survey and claims data. The
results will provide evidence needed to inform future strategies to ensure efficient use of health care resources
to reduce oral health disparities. The completion of this project will also enable Dr. Singhal to establish a
research program as an independent research investigator with support from her multi-disciplinary mentoring
and advising teams and the vibrant research community at Boston University.

Public health relevance
PROJECT NARRATIVE Access to dental care is a major public health problem among low-income adults, as evidenced by declining rates of dental care utilization, high unmet dental need, and the increasing rate of emergency department visits for dental problems by this vulnerable population. The research plan of this career development award aims to: 1) examine how state Medicaid policies regarding eligibility, coverage and dentist reimbursement impact access to dental care among low-income adults, and 2) develop a model to predict the impact of hypothetical policy changes. A clearer understanding of the relative effectiveness of policy alternatives available to states is critical to ensuring the efficient use of healthcare resources and achieving NIDCR’s strategic goal to reduce income-based disparities in access to and outcomes of oral health care services.